Data Management Core

Project Summary/Abstract, Data Management Core (DMC)
Malaria data sources are highly complex, multimodal, and are often siloed and unavailable in real-time. The Data
Management Core (DMC) personnel have previously developed elaborate data systems from the ground up for
international projects in low resource settings in multiple countries. The problem that the DMC seeks to address
is establishing sound, coordinated, research data capture and management systems and apply the latest bio-
statistical methods for synchronizing multi-site research projects for the West Africa International Centers of
Excellence for Malaria Research (WA-ICEMR). The DMC will provide centralized data capture, storage, and
management support to ensure the integrity of data for all projects and cores; monitors and coordinates timely
submission of data, metadata, and related data analyses to centralized data systems and NIH-approved portals,
including ImmPort; and provides biostatistics, data science, bioinformatics, and advanced data integration and
analysis support for the WA-ICEMR research projects. The goals of the DMC are to design and implement data
collection and management systems; facilitate data integration and use; and provide statistical, bioinformatics,
and technical support for carrying out the overall aims of this U19. The Core will build on the data management
systems developed for the proposed study to ensure quality, integrity, and accessibility of data throughout the
project period as well as to support the timely submission of data and statistical analyses to the broader scientific
community. The DMC will achieve these goals through the following Specific Aims: 1) Develop, test, validate,
and a data system to ensure the integrity of data for all projects and cores; 2) Provide study design, population
sampling, data visualization and biostatistical support for individual research projects to facilitate use of the latest
sophisticated statistical methods and publication of results; 3) Lead development of project metadata, common
data elements, and preparation of protocols, and standard operating procedures; 4) Monitor and coordinate
timely submission of data, metadata, and related data analyses to the broader scientific community; 5) Lead
DMC working group meetings, providing data capture, management, and analysis training.